PROJECT 3-Synaptic function in behaviorally-characterized aged rats in circuits of the entorhinal cortex and dentate gyrus

Aging frequently impairs cognitive functions associated with the medial temporal lobe
(MTL), particularly the formation of new memories, and it is also a major risk factor for
Alzheimer’s disease (AD). Recent studies in rodent models and humans identified hyperactivity
in specific circuits/subregions of the MTL, the lateral entorhinal cortex (LEC) and its downstream
target the dentate/CA3 subfields of the hippocampus, as a distinctive feature that associates
with impaired memory in aged individuals. A wealth of experimental and theoretical studies
indicates that the deleterious consequences of hyperactivity are multiple. Hyperactivity not only
compromises normal neural processing and the recruitment of plasticity mechanisms required
for encoding new memories, but it can also accelerate activity dependent pathogenic processes,
like Aβ production/deposition and spread of tau-hyperphosphorylation/toxicity along neural
connections.
In multiple brain areas, network activity is dynamically controlled primarily by GABAergic
circuits subserved by parvalbumin-positive inhibitory interneurons (PV-INs). Importantly,
mounting evidence indicates that dysfunction of these inhibitory circuits is a contributing factor in
age-related hyperexcitability, particularly in the earliest phases of AD. In adults, the inhibitory
output of the PV-INs is relatively stable, but the excitatory input onto PV-INs is comparatively
dynamic and plastic. In this context, a particularly interesting research target for hyperxcitability
during aging is Neuronal Pentraxin-2 (NPTX2), an extracellular protein released by excitatory
neurons in an activity-dependent manner that is crucial for stabilizing AMPA receptors at
synapses on PV-INs. Importantly, the genetic ablation of NPTX2 reduces these excitatory inputs
by half in mouse cortex, and in elderly humans low levels of NPTX2 in the cerebral spinal fluid
(CSF) correlates with reduced cognitive performance across the spectrum of aging/AD.
In this proposal we will examine the novel hypothesis that a reduction in NPTX2-
mediated stabilization of the excitatory connectivity onto PV-INs contributes to cognitive
impairment during aging. We will directly evaluate the functional status of multiple excitatory
inputs onto PV-INs within the MTL in a well-characterized rat model for individual cognitive
differences in aging. We will also test whether manipulating NPTX2 affects these inputs as
expected from the hypothesis. Testing the causal effect of NPTX2 in age-dependent cognitive
impairment in a comprehensive manner in multiple pathways, might help identifying potential
therapeutic targets to can alleviate age related cognitive decline.

Public health relevance
Narrative Aging is often accompanied by cognitive deficits and is also the major risk factor for Alzheimer's disease (AD). This multi-component research program studies a rodent model of naturally occurring variation in cognitive aging, with the goal of understanding the neurobiological basis of impairment and preservation of brain function that could contribute to vulnerability and resilience, respectively, in AD. Building on existing therapeutic progress, work within this program will continue to contribute to the development of effective therapeutic interventions for cognitive decline in aging with potential for slowing late-onset AD progression in its earliest phases.